Investigating the role of A20 and DREAM in adipogenesis and systemic sclerosis

PROJECT SUMMARY
The pathogenesis of systemic sclerosis (SSc) is not well understood, and effective treatments are lacking. A
unifying fibrosis paradigm is myofibroblast plasticity, by which quiescent resident myofibroblasts transform into
activated myofibroblasts during fibrosis development. Key interactions between vascular changes and early
immunological alterations occurs early in the course of disease. Loss of dermal white adipose tissue (dWAT) is
another major clinical manifestation of SSc skin fibrosis. Resident mature adipocytes are lost in human and
mouse skin tissues at early stage of fibrosis, yet the mechanisms that drive loss of mature adipocytes and their
contribution to tissue fibrosis are unknown. In this proposal, we will examine the role of A20 in endothelial and
adipocyte-specific differentiations to myofibroblasts (Endo-MT and AMT), and how attenuation of A20 in SSc
patients promotes fibrosis initiation and progression, and/or retards its resolution. We will use scRNA-seq
analysis to identify genes and pathways differentially regulated during Endo-MT and AMT and will correlate with
SSc sc-RNA-seq dataset to examine their contribution to early stage SSc. A20 repressor DREAM by binding to
A20 promoter suppress its expression. We will explore how by pharmacological/genetic approaches to increase
endogenous A20 function/expression by controlling DREAM will limit adverse tissue remodeling, opening the
door to novel therapeutic strategies. The project is of high impact since there are no appropriate treatments for
SSc. Moreover, the results will have a strong impact on myriad fibrosing diseases that currently lack effective
treatment.

Public health relevance
PROJECT NARRATIVE In this project we will investigate mechanisms of how A20 promotes adipogenesis and the absence/low A20 in scleroderma (SSc) patients will cause transdifferentiation of adipocytes to mesenchymal phenotype in SSc thereby initiating fibrosis. Furthermore, A20 suppressor DREAM is elevated and anti-correlated to A20 in SSc patients. We are going to study whether blocking DREAM function can restore A20 levels/activity and reduce fibrotic phenotypes in SSc.